Use of Modified mRNA for the Treatment of Diabetic Foot Ulceration

ABSTRACT
Impaired wound healing is an alarming problem in diabetes, attributed to the development of over 750,000
diabetic foot ulcerations (DFU) and 70,000 lower extremity amputations per year in the USA. Single-cell RNA-
sequencing (scRNASeq) analysis provides valuable insights into transcriptional features and disease
pathophysiology by allowing the profiling of individual cells in heterogeneous tissues. A recently conducted study
in our unit primarily focused on divergent characteristics between DFU patients who healed their ulcers (Healers)
and those who failed to heal them (non-Healers) and investigated molecular changes via scRNASeq analysis of
surgically removed DFUs. Our analysis revealed the enrichment of a unique population of fibroblasts,
overexpressing MMP1, MMP3, MMP11, HIF1A, CHI3L1, and TNFAIP6 genes in the Healers. Ongoing work in
our lab has shown that specifically designed alginate bandages that can provide controlled lipid nanoparticle
(LNPs) delivery of modified CHI3L1mRNA, IL-17AmRNA, FGF-2 and IL-2mRNA considerably improve wound
healing in diabetic db/db mice. Based on these findings, we hypothesize that topical wound treatment with new
biomaterials that can release the above mRNAs can lead to the development of new therapeutic approaches.
Furthermore, we hypothesize that combination of various mRNAs with specific temporal delivery can
physiologically imitate the activation of pathways that are associated with DFU healing.
To fully explore our hypotheses, we propose the following Specific Aims: 1.) Develop a modified-mRNA-LNPs
therapeutics delivery system to target different stages of diabetic wound healing and provide proof of concept
regarding their efficacy in wounds of diabetic mice. Alginate hydrogels fabricated into bandages capable of
sustained release will be employed to deliver mRNA-LNPs in 3D human skin equivalents and wounds of db/db
mice. We will identify the most efficient mRNA or combination and the most appropriate dosing and timing of
delivery in improving diabetic wound repair. 2.) Investigate efficacy in a larger animal model, the diabetic Yucatan
minipig and confirm mechanisms of action in both animal models. We will also examine mechanisms of action
of pro-healing mRNA(s) and will compare them to the results from the rodent studies. 3.) Conduct translational
studies in human diabetic wound healing to verify the therapeutic potential. We will conduct ex vivo wound
healing studies with discarded skin from patients with and without diabetes and in vivo studies with wounding of
human skin engrafted onto diabetic nude mice. We will also employ targeted multi-omics analyses to establish
molecular mechanisms of action and compare them with the ones that have been observed in our previous
extensive human studies. We believe that our proposal involves state-of-the-art “bench to bedside” research that
can culminate in the development of innovative new therapeutic approaches. Successful completion of the
project will facilitate the conduction of Phase I/II clinical trials in DFU patients.

Public health relevance
NARRATIVE The main goal of the application is to test the efficacy new biomaterials that release mRNA corresponding to genes shown to promote DFU healing in improving wound healing db/db diabetic mice, diabetic pigs, transplanted human skin onto immunocompromised mice and ex vivo human skin. Furthermore, we hypothesize that combination of various mRNAs with specific temporal delivery can physiologically imitate the activation of various pathways that are associated with DFU healing.